Dynamic Mechanisms of Fate Control during Epithelial Organ Renewal

Effective and safe stem cell therapies must build upon knowledge of how stem cells generate precise numbers of differentiated cells to meet the body's needs. In adult organ renewal, each stem cell division trig- gers a pivotal decision between asymmetric, symmetric-stem, and symmetric-terminal fates. To sustain con- stant numbers of stem and differentiated cells, these three fate outcomes must be collectively balanced. Con- versely, dysplasia or degeneration arise if fate balance is lost. Yet in contrast to the well-studied pathways that execute fate outcomes, the upstream events that decide between fate outcomes are virtually unknown. Our long-term goal is to understand the mechanisms that arbitrate the organ-wide balance of division fates. Toward this goal, here we probe the cellular basis of symmetric and asymmetric fate decisions?in vivo and in real time?by combining live imaging with the versatile genetic tools of Drosophila. Using the adult Dro- sophila midgut, we have made a pathbreaking innovation by developing long-term imaging of epithelial renewal at high cellular resolution in live animals. Our methodology enables individual stem cell divisions to be cap- tured in their native context and fate decisions to be visualized in real time. We will investigate three fundamental questions about the cellular and molecular nature of fate decisions. In Aim 1, we ask whether fate decisions are made by the dividing mother stem cell, by equipotent daughter cells, or a combination. Using live imaging, we will directly test the mother-control mechanisms of oriented cell division and fate determinant partitioning, and the daughter-control mechanism of Notch-mediated lateral inhi- bition. We will evaluate whether different mechanisms bias toward different fates, and examine whether initial fate decisions can be overturned by later-acting mechanisms. Aim 2 builds upon exciting preliminary data that stem cells are motile, which provokes the question of whether motility influences fates by altering proximity to spatially localized signals. We will determine how motility impacts fate decisions, probe the interplay between motility and fate outcomes, and identify the cytoskeletal regulators that instigate motility. In Aim 3, we turn to the adhesion junctions that define epithelial architecture and ask how this multicellular adhesive network inte- grates into fate decisions. We will separately perturb basal, lateral, and apical adhesion receptors on stem, daughter, and differentiated neighbor cells and parse how distinct receptors on different cell surfaces influence fate decision mechanisms and outcomes. Because epithelial stem cell biology and architecture are broadly conserved, the fate decision mechanisms uncovered here will potentially extend to epithelial organs in verte- brates, including humans. Ultimately, understanding the basic mechanisms that decide between division fates will open new therapeutic avenues to combat stem cell pathologies and promote organ regeneration.

Public health relevance
Our organs require constant cellular maintenance and renewal so that they function properly over the course of our lifetimes; this renewal is driven by adult stem cells that divide to replenish cells that are lost. Stem cells must strike a balance between different kinds of divisions to ensure that they make the right number of new cells; when this balance is off, the result is either tissue degeneration or dysplasia. We will study how individual stem cells choose between division types and identify the behaviors that lead to different division outcomes, important progress toward the long-term goal of opening new paths for therapeutic approaches to combat stem cell-based disease and promote organ regeneration.